Brain Injury and Dysmaturation in Newborns with Congenital Heart Disease Born Preterm

Brain Injury and Dysmaturation in Newborns with Congenital Heart Disease Born Preterm.
Abstract:
Preterm birth and congenital heart disease (CHD) are two of the most common sources of perinatal morbidity
in high resource countries. Both conditions are associated with acquired brain injury and adverse
neurodevelopmental outcomes. Very little is known about the combined risk for newborns with congenital
heart disease that are born preterm and how this risk is affected by variable approaches to palliative or
definitive surgical strategies to repair heart defects. In addition to brain injury, an increasing number of genetic
anomalies have been identified in CHD that may contribute to ND outcomes. Our extensive experience
imaging term babies with CHD and preterm babies without CHD, combined with high and increasing volume of
this vulnerable population at our two centers uniquely positions us to describe the risk and magnitude of
acquired brain injury as well as comparative brain development in CHD newborns born preterm with respect to
intervention strategies. Our long-term goal is to optimize neurodevelopmental outcomes. In this proposal, we
will leverage cross-center practice variability in timing and choice of surgical interventions, palliative versus
definitive, to determine the association of surgical intervention strategy with brain development and risk of brain
injury. We will also perform a comprehensive genetic evaluation to determine how genetic anomalies alter
susceptibility to brain injury and ND outcome.

Public health relevance
Narrative: Premature birth and congenital heart disease are two of the most common causes of sickness and death of newborns in developed countries. Both conditions are associated with brain injury and abnormal neurodevelopment. Our goal is to understand the best approach for treating heart defects to prevent brain injury and improve neurodevelopment in babies born early with heart conditions.